Evaluation of novel small molecule targeting lipid and energy homeostasis for treating obesity

ABSTRACT:
The goal of the project is to develop a safe and efficacious small molecule therapeutic to address obesity and
concomitant metabolic disorders, such as diabetes or insulin resistance, dyslipidemia, fatty liver disease, and
risk of cardiovascular disease events. To date, there are no approved therapies that can reliably reduce
multiple conditions associated with metabolic diseases over the long-term. Whilst recent milestone approvals
for anti-obesity (e.g., incretin analogs) therapeutics have provided new treatment options for patients, they are
limited and with shortcomings. ReRx-001 is an orally bioavailable small molecule therapeutic that acts upon
clinically validated targets involved in lipid homeostasis and energy metabolism and that has promising effects
in addressing obesity and associated metabolic disorders. Characterization of ReRx-001 activity by target
screens, benchmark studies, and combination studies demonstrate that the mechanism of action of ReRx-001
is distinct from current therapeutic approaches targeting energy intake (e.g., appetite regulation). Our
preliminary proof-of-principle studies in various diet-induced obesity and metabolic dysfunction-associated fatty
liver disease mouse models have found that ReRx-001 treatment effectively addresses metabolic,
inflammatory, and fibrotic disease markers with no apparent adverse side effect profiles. In this Phase II
application, we will investigate translational efficacy and define treatment outcomes in higher species, namely
diet-induced obese nonhuman primates, as well as initiate preliminary pharmacokinetic and toxicology studies
in rodent species and nonhuman primates. Along with the existing preclinical data, results generated from the
proposed studies will culminate in IND-enabling activities and a pre-IND meeting with the FDA for additional
clinical guidance and study design.

Public health relevance
NARRATIVE - Public Health Relevance Statement: The goal of the project is to develop a therapeutic capable of addressing obesity and associated comorbidities. The degree and incidence of overweight and obesity is the U.S. and worldwide has been rising and becoming an increasingly complex issue that encapsulates socioeconomic, psychological, and biological implications, culminating in a public health crisis. If left unaddressed and current trends prevail, an estimated 1 in 2 adults worldwide will be living with overweight or obesity with an estimated global economic impact of $4.3 trillion annually by 2035. A lack of diverse therapeutic solutions to concomitantly address the associated metabolic complications have raised unmet and serious needs to improve standard of care for future treatment options. We have identified a small molecule candidate targeting energy expenditure and lipid homeostasis capable of addressing multiple pathologies of severe metabolic disease, and we will develop this compound into a therapeutic.